Effect of Lumbar Hypo & Hypermobility on Sensory Responses to Spinal Manipulation

DESCRIPTION (provided by applicant): Manual therapy practitioners frequently include assessment of spinal joint mobility in their clinical examination and treatment of patients with low back pain. There is increasing evidence that clinical identification of spinal joint hypo- and hypermobility subgroups along with correspondingly tailored manual therapy treatment approaches can lead to more successful therapeutic outcomes. For example, individuals with low back pain and spinal hypomobility have been shown to respond better to spinal manipulation than those with spinal joint hypermobility. What underlying biological/neural mechanisms could be responsible for the different clinical responses from these subgroups when treated with spinal manipulation? This question motivates this career development plan which allows the candidate to accomplish his immediate goals of: a) working with an animal model that combines simulated spinal manipulation with peripheral neural recordings from lumbar paraspinal muscles and b) attaining knowledge of musculoskeletal biomechanics pertinent to the applied spinal loading that occurs during spinal manipulation through didactic coursework. In this study, an established cat lumbar spine model will be used to determine the effects of proximal, distal, and bi-segmental spinal joint hypo- and hypermobility on paraspinal muscle spindle discharge during simulated high velocity low amplitude spinal manipulation of different durations (25-400ms). Spinal joint hypomobility will be created by placing unilateral bone screws through the facet joint; hypermobility will be created via unilateral facetectomies. This study will reveal relationships between spinal joint dysfunction and sensory feedback related to a specific manual therapy intervention (spinal manipulation) with demonstrated effectiveness in the treatment of low back pain. By adding spinal joint hypo- and hypermobility conditions to an established animal model used to investigate spinal manipulation, this career development award provides the candidate with tools and experience to accomplish his long-term career goal of determining how spinal manipulation in the presence of spinal joint dysfunction affects the central nervous system. The candidate is a second generation chiropractor and this career development plan will be completed at the largest chiropractic research center in the world (Palmer Center for Chiropractic Research) which recently received a NIH/NCCAM grant to establish a four year multi-disciplinary Developmental Center for Clinical and Translational Science.

Public health relevance
PUBLIC HEALTH RELEVANCE: Back pain is the second most frequent reason for physician visits and the third for surgery. This animal study is directed toward understanding the consequences of restricted or excessive spinal joint mobility on neural responses to a commonly used manual therapy treatment (spinal manipulation) for back pain. The results of this study may provide a rationale for clinically tailoring manual therapy treatment approaches for specifically identified spinal joint dysfunctions. Project Narrative: Back pain is the second most frequent reason for physician visits and the third for surgery. This animal study is directed toward understanding the consequences of restricted or excessive spinal joint mobility on neural responses to a commonly used manual therapy treatment (spinal manipulation) for back pain. The results of this study may provide a rationale for clinically tailoring manual therapy treatment approaches for specifically identified spinal joint dysfunctions. __SpecificAimsTextDelimiter__ Effect of Lumbar Hypo & Hypermobility on Sensory Responses to Spinal Manipulation The vertebral column is composed of multiple osseous segments separated by discs and connected by ligaments with viscoelastic properties and acted upon by multiple muscles which are crucial for providing stability while maintaining intervertebral mobility. Manual therapy practitioners frequently include assessment of spinal joint mobility in their clinical examination and treatment of patients with low back pain. There is increasing evidence that clinical identification of spinal joint hypo- and hypermobility subgroups along with correspondingly tailored manual therapy treatment approaches can lead to more successful therapeutic outcomes in patients with low back pain (Fritz et al. 2005, Hicks et al. 2005, Childs et al. 2004). Recent animal studies suggest that impulse duration and not force amplitude during simulated spinal manipulation plays a prominent role in paraspinal sensory feedback responses related to simulated spinal manipulation (Pickar et al. 2007, Sung et al. 2005). Therefore, basic research determining how spinal joint hypo- and hypermobility at adjacent (proximal) and non- adjacent (distal) vertebrae affects sensory feedback during and following spinal manipulation of different impulse durations may provide important insight into my long-term goal of identifying the biological mechanisms responsible for the successful therapeutic outcomes of manual therapy. Several types of receptive nerve endings can provide proprioceptive feedback from spinal tissues. Muscle spindles are generally thought to be the most important source of information for vertebral position and movement. The effect of proximal, distal, and/or multi-segmental spinal joint hypomobility and spinal joint hypermobility on paraspinal muscle spindle feedback is unknown. The objective of the current proposal is to determine the effects of proximal, distal, and bi-segmental spinal joint hypomobility and spinal hypermobility on lumbar paraspinal muscle spindle discharge in response to simulated spinal manipulation (SM) of different durations in a feline lumbar spine model (Fig. 1). The proposed experiments are based on three hypotheses: HYPOTHESIS 1: Mono-segmental hypomobility at the segment of the manipulation will decrease muscle spindle discharge at the same segmental level during short duration (<150ms) SM while mono- segmental hypermobility will have the opposite effects (proximal effects). HYPOTHESIS 2: Mono-segmental hypomobility and short duration SM at a distant vertebral level will increase muscle spindle discharge while distant mono-segmental hypermobility and short duration SM will decrease spindle discharge (distal effects). HYPOTHESIS 3: Bi-segmental hypo- and hypermobility will have cumulative proximal effects on muscle spindle discharge during distant SM. The following Specific Aims will be used to test these hypotheses (Fig. 1): SPECIFIC AIM 1 (SA1): Determine the effects of proximal mono- segmental hypo- and hypermobility at the L5/L6 level on L6 paraspinal muscle spindle discharge in response to different L6 SM impulse durations (25-400ms) delivered under force control. SPECIFIC AIM 2 (SA2): Determine the effects of distant mono- segmental hypo- and hypermobility at the L4/L5 level on L6 muscle spindle discharge in response to distant L4 SM of different impulse durations (25-400ms) delivered under force control. SPECIFIC AIM 3 (SA3): Determine whether bi-segmental hypomobility and hypermobility (at L4/L5 & L5/L6) has additive effects on L6 muscle spindle discharge in response to L4 SM of different impulse durations (25-400ms) delivered under force control.